The Pennsylvania Food Protection Rapid Response Team Phase II

ABSTRACT During the course of the initial three-year project cycle, Pennsylvania has created a solid foundation for the PA Rapid response Team to refine, maintain, and mature for the future. The five phases of food/feed response have been addressed in the PA's RRT plans, trainings, meetings, investigations, and exercises. Further, the four core elements of collaboration, communication, written policies and procedures, and resources necessary to achieve an effective RRT capability in all phases have been developed, trained, tested, and exercised amongst the RRT advisory group members. To sustain and advance the PA RRT's work additional time and resources are needed.

Public health relevance
Narrative Due to the extensive number of food facilities in Pennsylvania, current conditions provide for a distinctive opportunity for continued identification, development, and testing of emergency response best practices, strategies and procedures to enhance the ongoing efforts of Pennsylvania Department of Agriculture and its partner agencies for reaction to food/feed outbreaks that impact the Commonwealth. Fundamentally, the goal of this cooperative agreement application is to augment long-term improvements to Pennsylvania's capability for integrated food safety response by coordinating efforts; including strengthening the food/feed regulatory components, surveillance protection programs in synchronization with epidemiology and laboratory competencies. Providing a seamless transition from routine investigations and responses to severe, multifaceted incidents; this platform will continue to address these complex foods and/or feed emergencies requiring response resources exceeding or anticipated to exceed the capacity of one or more agencies and builds on integrating established departmental routine procedures.